Mechanisms of nuclear morphology regulation

Project Summary: This is a proposal to renew the Levy lab MIRA. Fundamental cell biological questions
concern the regulation of organelle morphology. In particular, nuclear morphology is often altered in cancer
cells in a ploidy-independent manner, a change used for cancer diagnosis and staging. It is not known if
cancer-related changes in nuclear morphology are a cause or consequence of disease due to a gap in our
knowledge of the mechanisms that regulate nuclear morphology. In broad terms, our research focuses on
uncovering fundamental and conserved mechanisms that regulate nuclear size and shape. Since 2018,
my lab has published 10 research papers and 8 reviews/protocols that have advanced goals from the previous
MIRA and that lay the groundwork for the current proposal. Whereas our past studies relied on biochemically
tractable Xenopus egg extracts that reconstitute nuclear assembly, we are now exploring new areas and
developing complementary approaches, including microfluidic-encapsulation of extract, the use of actin-intact
and cycling extracts, in vivo developmental studies in sea urchin and Xenopus embryos, differentiation studies
using human induced pluripotent stem cells (iPSCs), and collaborative work in C. elegans. We will address
four questions over the next 5 years. (1) What mechanisms control nuclear size and shape under normal
and stress conditions? Following up on our imaging-based RNAi screen, we will dissect novel mechanisms of
nuclear morphology control using Xenopus egg extracts and Xenopus and sea urchin embryos, focusing on
cancer-relevant hits. We will also investigate how osmotic, oxidative, and proteotoxic stress influence nuclear
morphology. (2) How do cytoplasmic volume and shape influence organelle morphology and positioning?
Using a bottom-up microfluidic approach, we will generate synthetic cells with increasingly complex and native
attributes to address questions at the intersection of size control, cytoskeletal organization, and cell cycle
timing; these experiments will be complemented by in vivo studies in sea urchin embryos. (3) How is nuclear
morphology regulated during development and differentiation? Leveraging new mechanistic insights, we will
investigate how nuclear morphology affects embryonic development. Using iPSCs, we found that nuclear
morphology and lamin dynamics change significantly during differentiation, motivating our future work to
uncover the underlying mechanisms for these effects. (4) How is nuclear identity determined in a multinucleate
syncytium? In new collaborative work, we will investigate transcriptional coordination and specialization in the
multinucleate C. elegans hypodermis. Our work is bolstered by ongoing productive collaborations that use
diverse interdisciplinary techniques including high-resolution microscopy, RNAi screening, microfluidics and
microfabrication, and multi-omics approaches. Our overall vision is to use the mechanistic knowledge
gained to address how nuclear morphology affects cell and nuclear function, including nuclear
organization, gene expression, development, cell differentiation, and cancer progression.

Public health relevance
Project Narrative: Nuclear morphology is often deregulated in cancer cells, many cancers are diagnosed and staged based on graded increases in nuclear size, and little is known about the causes or effects of nuclear morphology changes in cancer. We will identify regulators of nuclear size and shape, elucidate mechanisms of nuclear morphology regulation, and use this information to investigate how nuclear morphology affects embryonic development, cell differentiation, and carcinogenesis, shedding light on novel approaches and targets for the diagnosis and treatment of cancer. Aberrant nuclear morphology in cancer might be necessary for cell homeostasis and viability, so therapeutic manipulation of nuclear morphology could provide a means to selectively target and kill only affected cells.